The Big Ten Electronic Health Record Consortium (Big Ten-EHRC)

Project Summary/Abstract The Goal of this application is to create a consortium of Cancer Centers that will communicate and coordinate with the NCI and with EHR vendors to facilitate and harmonize rapid implementation of EHR investigative treatment plans for the conduct of NCTN clinical trials. Specific AIMS include: Aim 1. To retrospectively analyze similarities and differences of EHR treatment plans design and implementations across the member institutions in the BTCRC; Aim 2. To develop novel tool kits that promote optimized activation of NCTN clinical trials by facilitating and expediting EHR implementation of treatment plans; Aim 3. To prospectively validate these EHR treatment plan implementations across Big Ten institutions and other non-Big Ten institutions

Public health relevance
Narrative The Big Ten Electronic Health Record Consortium (Big Ten-EHRC) is ideally suited “to develop processes across multiple NCI-supported Cancer Centers and community sites that will facilitate the development of single instances EHR clinical trial treatment plans”. The Big Ten-EHRC will use the established Big Ten Cancer Research Consortium (BTCRC) partnership to complete this project.